North Colony Field Cage Shade Structure Bid Build

PROJECT SUMMARY
The California National Primate Research Center (CNPRC) has supported the production
of Specific Pathogen Free rhesus macaques for HIV/AIDS research since 1990. The initial
agents selected for exclusion included Simian Retrovirus (SRV), Simian
Immmunodeficiency Virus (SIV) and Simian T Cell Lymphotrophic Virus (STLV), based on
their potential to interfere with AIDS research studies. The SPF program also included
Herpes B virus due to the risk posed by the presence of this virus in macaque tissue and
body fluids to personnel working with rhesus macaques. Initial colony development was
based on test and removal with a high frequency of testing to identity seropositive or virus-
positive animals that had the potential to transmit the viruses in question. This created a
colony of Specific Pathogen Free (SPF4) Indian origin rhesus macaques for AIDS
research.
The CNPRC has 24 half-acre field corrals that provide housing for the rhesus monkey breeding
colony. Currently four are assigned to the U42 project to support the production of pedigreed
SPF4 animals for AIDS research. Each of these field corrals can house approximately 150
animals but typically are formed with smaller populations of twenty males and fifty females. A
typical breeding group consists of animals belonging to several age groups characterized by a
strict dominance hierarchy. The CNPRC maintains detailed behavioral and social records of
each social group to facilitate management decisions pertaining to breeding needs, research
support and the colony’s wellbeing. Established matrilines along with several adult males
provide social stability in the group formation and subsequent years. These animals are a long-
term breeding resource and serve as a national resource for infants, juveniles, adults, and aged
animals for use in biomedical research by investigators from throughout the United States. 18 of
the existing field cages at the CNPRC already have steel overhead structures to protect the
animals from the heat in the summer and the rain in the winter.
Approximately 10 of these corrals were constructed in the 1970’s and have required repair and
maintenance over the past 50 years. 6 of the corrals have either structural problems and/or
deteriorating shade covers that were put in place to shelter the outdoor animals from both sun
and rain. These canvas shade structures are damaged by wind and the sun and need
replacement every few years. The requested funds will help purchase one steel overhead
shelter for one of the corrals. This project will purchase a replacement 19' high, 100’ wide, and
60’ long steel-frame canopy covers (similar to patio structures) that will cover approximately
one-quarter of a corresponding half-acre field corral, or 6,000 square feet. The structures will
include steel framing, metal roofing, and concrete footings. Each structure has a life span of 50
years. Depending on the corral population each corral can produce between 25 to 35 infants per
year.
This proposal aligns with the aims of the parent U42 grant (U42OD010990) by supporting the
provision of healthy, SPF Indian origin rhesus macaques for AIDS research and facilitating their
care and the ability to collect biological samples safely and efficiently for research and SPF
colony maintenance.

Public health relevance
U42 ADMINISTRATIVE SUPPLEMENT TITLE “U42 Breeding Corral Shelter Renovation” PROJECT NARRATIVE The application is seeking funding for alterations and renovations to one half-acre corral, by replacing a worn canvas shade structure with a steel overhead canopy that will better and more reliably protect the U42 colony assigned rhesus macaques housed in that space from sun, wind and rain. RESOURCE SHARING PLAN The resource sharing plan for the proposed renovation of one half-acre U42 SPF corral is that as part of the CNPRC centralized animal care and use program the enclosure will be used to support and maintain the pedigreed, SPF breeding colony housed there. The animals produced in this corral will be available for use by all Core and Affiliate AIDS investigators at the CNPRC and available for NIH funded AIDS research nationwide. This includes the other six NPRCs as well as research institutions using rhesus macaques for NIH supported AIDS related projects. RIGOR, REPRODUCIBILITY, AND SEX The proposed “U42 Breeding Corral Shelter Renovation” project will promote consistency and standardization by reliably improving the welfare of corral housed pedigreed, SPF animals for NIH funded AIDS investigators, both internally and nationwide. The CNPRC AIDS investigators consistently conduct research projects with an appropriate sex balance except in studies where the male or female reproductive tract is the focus of the research.